Research Training in the Neuroscience of Aging

Project Summary
The program on Research Training in the Neuroscience of Aging provides predoctoral students in Neuroscience
with an integrated training experience in the laboratories of nationally and internationally recognized faculty. The
predoctoral training program builds on an exciting, translationally relevant curriculum taught in years one and
two of graduate school that has been awarded NIH support through the Jointly Sponsored Predoctoral Early
Stage T32 Training Program mechanism (T32 MH087004). This training program is the first at Mount Sinai to
focus specifically on the neuroscience of aging and age-related neurodegenerative diseases (primarily
Alzheimer's disease), complementing Mount Sinai's historical concentration and strength in research in these
areas. Outstanding training faculty in this program share common research interests in the mechanisms of brain
function in health and disease, employing a diversity of experimental approaches and working at levels of
analysis ranging from molecular neurobiology to human neuropsychology and neuroimaging. The training
program specifically encourages participation of faculty mentors whose research grants directly focus on aging
neuroscience research, while not excluding those whose research expertise is critically important for the
interdisciplinary training we seek to impart. Through their coursework, predoctoral trainees will have received a
solid foundation in basic neurobiology and the pathophysiology of neurological and psychiatric diseases, as well
as biostatistics and the responsible conduct of research. Advanced coursework includes two seminar courses,
one on the biology of aging and one on the neuroscience of aging, complementing the broad foundational
coursework in neuroscience. Selection of a research mentor is made in a collaborative environment that actively
promotes multidisciplinary, integrative research. Research training also has a ‘work in progress’ component, to
foster important interdisciplinary interactions, hone presentation and writing skills, and improve awareness of
ethical issues. This program began in September of 2015 with 4 predoctoral training slots and to date has
supported 8 students, 2 of whom have already competed their PhD training. Using this approach, the program
on Research Training in the Neuroscience of Aging provides predoctoral students with the guidance and
experimental tools, in the laboratories of our training faculty, to launch successful, productive, and independent
careers in aging research.

Public health relevance
Project Narrative We describe a training program that seeks to identify a group of highly talented predoctoral students to become the next generation of researchers in the neuroscience of aging who will provide significant advances in the understanding and treatment of age-related changes in brain function and age-related neurodegenerative conditions such as Alzheimer's disease. Predoctoral students are offered a flexible, interdisciplinary program of course work, coupled with basic and/or translational research in the neuroscience of aging, to achieve these important goals that will contribute to improved public health.